COMPUTER AIDED TRACKING OF MYOSIN COATED BEADS ON ACTIN FILAMENTS

A manual system using a TV camera, VCR, and an IBM PC/XT clone has been put together to track particles moving in a microscope field. All programming is done in the computer language "C".